Marine Natural Products Gordon Research Conference and Gordon Research Seminar

Project Summary
Marine Natural Products continue to play a critical role in the treatment and prevention of human diseases. Most
of our small molecule drugs are either derived from or inspired by natural products. While the majority of them
is based on terrestrial natural products, the marine environment remains a largely unexplored frontier that
harbors the greatest biodiversity on our planet. This rich biodiversity in turn translates into chemical diversity and
potentially new pharmacology as a basis for the discovery of new strategies for the management of human
health. The unique chemical scaffolds of marine natural products that consequently displays unique
pharmacology, provides structure-function pairs for target validation and drug development. In recent decades
marine natural products researchers have searched for ways to effectively harness new methodologies to mine
the biosynthetic potential of marine organisms. With advances in sampling strategies, genomics, synthetic and
chemical biology, complimented by new analytical and synthetic chemistry tools, this field has been addressing
the challenges and gaining major insight into structural novelty, supply issue and target identification, thus
overcoming the hurdles in the current era. The field has been emphasizing the development of databases and
computational tools, including machine learning, to analyze the massive genomic and structural information.
Breakthroughs in fields such as cryo-EM, and other enabling technologies as antibody-drug conjugation have
now penetrated the field of marine natural products, synergizing with other methods to decipher target
interactions. As we anticipate this huge progress to lead to a new wave of drugs to help combat the rapidly
evolving trends in human diseases, the synergistic efforts in multiple disciplines related to marine natural
products science will be the focus of the 2024 Marine Natural Products GRC that consequently aligns well with
the mission of NCCIH. Subtitled “From Discovery to Production via Function to Applications”, the meeting will
provide an exceptional platform to all marine natural products researchers at various career stages and coming
from all parts of the globe while representing research in both academia and industry, to gather, exchange,
network and be inspired by the peers in the field. Presentations and discussions will address themes from various
perspectives, including technologies, disease indications, biological targets and applications at the molecular,
cellular and organismal levels as well as ecological context. Attendees bring diverse and cross-disciplinary
expertise in bioorganic, medicinal, and pharmaceutical chemistry, and ecology, as well as in genomics,
biotechnology, bioinformatics and molecular pharmacology. Ample opportunities for scientific exchange in and
outside of meeting sessions, collaboration, and networking will facilitate the pivotal goal of connecting and
educating marine natural products researchers. NIH support will be directed to fund the participation of graduate
students and postdoctoral attendees as presenters and discussion leaders at the 2024 GRS, and early career
as well as established scientists, while emphasizing the participation of females and members of groups that are
traditionally under-represented in science.

Public health relevance
Narrative Marine natural products, derived from the richest biodiversity resource of our planet, represent diverse chemical scaffolds with new pharmacology to address issues in human diseases. The 2024 Marine Natural Products Gordon Research Seminar (GRS) and Gordon Research Conference (GRC) will bring together up to 200 students, postdocs, early career and established investigators, providing a platform for discussing innovative research ideas in a highly interactive forum. The scientific program emphasizes latest advances in the field of marine natural products science, enabling technologies, novel structure scaffolds, pharmacology, and supply issues that are critical for developing new therapeutics to combat infectious diseases, cancer, and other diseases.